Control of Long-lived HIV Cellular Reservoirs in memory CD4+ T cells by Bach2

Abstract
Despite effective antiretroviral therapy (ART), HIV-1 mainly persists in a small pool of latently
infected, resting memory CD4+ T cells in people living with HIV-1 (PLWH). Virus eradication with
ART alone will not be possible. The stability of the viral reservoir is a consequence of infection of
cells that either have expanded or are destined to expand in response to cognate antigens or
cytokines. CCR5 and CXCR4 are two co-receptors for HIV-1 entry. CCR5-tropic virus is critical
for the establishment of infection and dominates the pool of viruses in blood and tissues early
after infection. In PLWH, latent HIV-1 is predominantly CCR5-tropic, which is a reflection of
selective transmission and dominant replication of CCR5-tropic virus before ART initiation. CCR5
is expressed predominantly by terminally differentiated CD4+ T cells which lose proliferation
capacity and are prone to cell death. To seed the latent reservoir, CCR5-expressing CD4+ T cells
are infected, carry integrated and transcriptionally silent HIV-1 provirus, and differentiate into long-
lived memory cells. To maintain the latent reservoir, cells carry integrated HIV-1 proviruses
proliferate despite potential viral cytopathic effects or immune clearance. Therefore, studies on
the mechanisms suppressing terminal differentiation of CCR5+CD4+ T cells are significant. In this
study, we plan to address the following three questions. 1) How does Bach2 inhibit terminal
differentiation of CCR5+CD4+ T cells and how does it impact viral reservoir seeding in humanized
mice? 2) Can Bach2-mediated differentiation of CCR5+CD4+ T cells results in long-lived memory
cells with proliferation capacity? 3) Can we target Bach2 or its downstream molecules to prevent
HIV reservoir seeding? Understanding this process can help us develop strategies to block
seeding or expansion of the stable viral latent reservoirs in vivo.

Public health relevance
Project Narrative A small pool of long-lived memory CD4+ T cells carrying latent HIV is the major barrier to viral eradication. In this proposal, we aim to study the molecular mechanisms governing the survival and expansion of HIV-infected memory CD4+ T cells.